INTERACTIONS IN VENTILATORY CONTROL DURING EXERCISE

The overall objective of this project is to further our understanding of basic processes involved in the control of breathing. The proposed experiments are designed to investigate interactions between exercise and factors that affect ventilation at rest. In accordance with the requirements of gas exchange, the ventilatory response to exercise is enhanced or attenuated when resting ventilation and blood gases are changed by various chronic treatments, regulating the arterial carbon dioxide tension with the same precision in exercise regardless of its initial value. it is hypothesized that changes in resting ventilatory drive elicit a common mechanism that actively modulates the ventilatory response to exercise. The objective of these experiments is to test this hypothesis and to further investigate the nature of this postulated mechanism. Awake goats trained to wear a respiratory mask and run on a treadmill will be used as an experimental model. To assess the generality of the postulated mechanism which modulates exercise hyperpnea to match the requirements of gas exchange, ventilatory and blood gas responses to exercise will be monitored with a variety of acute treatments that alter resting ventilation and blood gases with varied mechanisms of action. Specific attention will be devoted to hypoxia/exercise interactions using an experimental preparation that allows perfusion of the carotid body chemoreceptors to be isolated from the systemic circulation an awake exercising animal. To further investigate the role of chemoreceptors, experiments will be conducted after carotid body denervation and by using an additional treatment that increases resting ventilation but that changes blood gases int he reverse direction from normal. The role of pulmonary afferents in modulating the ventilatory response to exercise will be investigated via chronic hilar nerve denervation. Finally, the role of chest wall afferents in modulating the ventilatory response to exercise will be investigated via chronic thoracic dorsal rhizotomy. These experiments will further our understanding of interactions between resting ventilatory drive and ventilatory control in exercise. An understanding of these basic processes is fundamental to understanding the effects of many disease states or therapeutic treatments that alter resting ventilation and blood gases.